Phase 0/I dose escalation trial of MT-125 monotherapy in recurrent high-grade gliomas

PROJECT SUMMARY
An area of significant unmet need is the treatment of glioblastoma (GBM), an aggressive, fast-growing
and lethal brain cancer that represents half of all malignant brain tumors. Untreated, GBM is fatal within three
months, and due to its high rate of recurrence and invasive nature, the current standard of care, consisting of
safe maximal tumor resection, radiation therapy and chemotherapy, only extends survival following initial
diagnosis to one year. Invasion and proliferation are defining phenotypes of GBM, and GBM cells do only one
or the other. However, blocking invasion stimulates proliferation and vice versa, implying that an ideal
therapeutic needs to block both processes simultaneously. Genetic interventions have shown that
simultaneous disruption of two non-muscle myosin II molecular motors (NMIIA and IIB) meet these criteria.
However, the translational potential of this research has been limited by the lack of a clinically safe, CNS-
penetrant NMII small molecule inhibitor. Following extensive medicinal chemistry efforts to optimize selectivity,
safety, and tolerability, MT-125 was identified. MT-125 is a well-tolerated, dual small molecule inhibitor of
NMIIA and IIB with a high degree of brain penetrance, a requirement for an effective GBM therapeutic.
Preclinical in vitro and in vivo studies show that MT-125 blocks both invasion and proliferation and extends
survival. Due to its unique mode of action, MT-125 synergizes with FDA approved, CNS permeant kinase
inhibitors and with radiotherapy to dramatically extend survival in both genetically engineered and patient-
derived mouse xenograft models of GBM. MT-125 is active against IDH WT/MGMT unmethylated GBMs,
which resist all current medical therapies. Myosin recently received Orphan Drug Designation from the FDA
for the treatment of malignant gliomas with MT-125 after an in-depth review of the company’s data package
and we received supportive Pre-IND feedback from the FDA Division of Oncology 2. The goal of this SBIR
Phase IIB Bridge application, which builds on the company’s currently funded NCI Fast Track STTR with Dr.
Rosenfeld (Mayo Clinic), is to perform a Phase 0/1b clinical trial with MT-125. The primary endpoints will
be to determine the optimal biologocial dose (OBD) of MT-125 and assess drug distribution within tumor
tissues. Systemic pharmacokinetics will be evaluated as a secondary endpoint. Based on translation to human
dose equivalents, our efficacy and toxicity testing in two species to date indicate that the proposed starting
dose is potentially therapeutic. Therefore, secondary endpoints will also gather preliminary data on efficacy
through measures of response rate, progression free survival, and overall survival. Due to MT-125’s ability to
block proliferation through inhibited cytokinesis, the compound increases the number of multi-nucleated cells
within tumors. This represents a potential measure of target engagement, and we will, therefore, assess the
presence of multi-nucleation within resected tumors in Phase 0.

Public health relevance
PROJECT NARRATIVE Glioblastoma is an aggressive, fast-growing brain cancer that represents nearly half of all malignant brain tumors and, due to the high rate of recurrence, current treatment options only extend survival following initial diagnosis to one year. Building on years of basic research into the biology of glioblastoma identifying nonmuscle myosin II as a potential therapeutic target, an interdisciplinary team has been brought together with the necessary expertise in glioblastoma and myosin biology, drug development and the clinical treatment of glioblastoma to advance the small molecule inhibitor MT-125 for glioblastoma therapy. This application will support execution of a first-in-human Phase 0/1b clinical trial of MT-125 in glioblastoma.